Preventing GVHD by inhibition of alloantigen presentation in the gut

Abstract
Blood cancers account for approximately 10% of all malignancies. In addition, non-malignant bone marrow failure
diseases such as aplastic anaemia, or immunodeficiency diseases such as severe combined immunodeficiency,
are life-threatening diseases and allogeneic bone marrow transplantation (BMT) is a preferred curative therapy
for these serious conditions. BMT outcomes are limited by transplant related complications, mainly graft-versus-
host disease (GVHD) and opportunistic infections. Indeed, 15-20% of BMT patients will develop severe GVHD
that is fatal, particularly when involving the GI tract. Current prevention and treatment of GVHD rely on the broad
suppression of T cells and remains suboptimal. The initiation and maintenance of T cell responses are dependent
on activities mediated by antigen-presenting cells (APC) but the types of APC that initiate GVHD and the factors
that promote their function is currently unknown. This is the focus of this proposal. In particular, we will build on
our preliminary data to test the hypothesis that lethal acute GVHD is initiated in the ileum. We will utilize cutting-
edge mechanistic preclinical murine studies with parallel clinical analysis, using advanced flow cytometry,
RNASeq, and REAP/CITE-seq to focus on antigen presentation in the gastrointestinal tract, identifying clinically
tractable pathways that will prevent the development of lethal acute GVHD, whilst permitting GVL and pathogen-
specific immunity that are initiated in primary and secondary lymphoid organs. The proposal will lead to new,
rapidly testing therapeutic approaches to prevent GVHD based on the inhibition of disease initiation (i.e.
alloantigen presentation) rather than broad T cell suppression in the late effector phase of disease, as is current
practice.

Public health relevance
Narrative Blood cancers account for approximately 10% of all malignancies and allogeneic bone marrow transplantation (BMT) is a major curative therapy, but is limited by transplant related complications, predominantly-graft-versus host disease (GVHD) that is often fatal. The proposal will study and define rapidly testable therapeutic approaches to prevent GVHD based on preventing the initiation of disease (i.e. alloantigen presentation) rather than broad suppression of T cells in the late effector phase of disease, as is current practice. In this manner we hope to define a new strategy to prevent the side effects of transplantation, whilst permitting the development of robust immunity to pathogens.